Identifying Effective School-Based Health Center Models and Practices Nationally

ABSTRACT
School-based health centers (SBHCs) provide primary care, mental health care, and other health services in or
near schools that serve youth populations who otherwise may have limited access to care. Although research
has documented SBHCs’ impacts on healthcare access and outcomes, only limited research has assessed
which specific SBHC models and practices are most effective. Rigorous research is needed to inform the
selection and implementation of SBHC models and practices, particularly given the expansion and rapidly
changing landscape of SBHC operations and the heightened recognition of and need to address disparities in
access. We will address these knowledge gaps by capitalizing on a longstanding partnership between our
University of California, San Francisco and School-Based Health Alliance teams collecting national data on
SBHCs. We will first collect comprehensive data on staffing models and healthcare delivery practices from a
representative sample of SBHCs nationally. This will help us create a standard classification of SBHC models
and practices to strengthen SBHC research. We will then conduct a qualitative study to identify barriers and
facilitators, such as care coordination; screening, treatment, and referral practices; and school health system
integration, that can hinder and facilitate the provision of equitable care in SBHCs. Lastly, we will examine
national data on schools with and without SBHCs to understand whether access to SBHCs, and which service
models in particular, are associated with reduced disparities in academic outcomes, such as graduation rates,
chronic absenteeism, and disciplinary actions.
This 4-year mixed methods study will describe current trends in SBHC models and practices and identify the
models and practices associated with reduced disparities. Our specific aims are to: 1) describe current trends
in SBHC staffing models and practices nationally and create a classification system to strengthen future
research, design, and implementation; 2) determine the care delivery, coordination, and school health system
integration practices associated with more equitably serving youth who disproportionately experience
disparities; and 3) examine the association between SBHC models and academic outcomes by race/ethnicity
nationally. Findings from our research will inform SBHC policy, funding, and program decisions, and hold
promise to elucidate the role SBHCs can play in reducing health inequities.

Public health relevance
PROJECT NARRATIVE Rigorous research is needed to inform the selection and implementation of school-based health center (SBHC) models and practices, given the expansion and rapidly changing landscape of SBHCs nationally and heightened recognition of health disparities. This four-year mixed methods study will identify SBHC models and practices associated with reduced health and academic disparities. Findings will inform SBHC policy, funding, and program decisions and help better understand the role SBHCs can play in serving historically marginalized youth's health and educational success.